Deciphering brain mosaicism in drug-resistant epilepsy at cellular resolution

Project Summary
This administrative supplement will provide a predoctoral research training and mentorship program for Ms.
Sydney Townsend under the parent project R01NS129784 entitled “Deciphering brain mosaicism in drug-
resistant epilepsy at cellular resolution.” Ms. Townsend’s goal is to study the long-term consequences of pediatric
drug-resistant epilepsy, while developing her own analytical skills with a focus on single-cell transcriptomic and
epigenomic data. Early-life seizures, particularly those that are difficult to control with medication, have profound
consequences for brain development and function later in life. Up to half of children with epilepsy exhibit
intellectual disability and long-term deficits in communication, cognition, and behavior. Therefore, it is a critical
need to understand how early-life seizures alter brain development to develop treatment opportunities. Epilepsy
has been linked to transcriptional and epigenetic remodeling in the adult brain, but a major barrier to
understanding its developmental effects has been dissecting the acute vs. long-lasting contributions of individual
cell types. Understanding both acute and long-lasting molecular responses to early-life epilepsy on a cellular
level would inform the mechanisms through which long-term cognitive and behavioral deficits arise. This
application aims to bridge this gap in knowledge by using cutting-edge single-cell multiomics techniques to
investigate epigenetic and transcriptional changes in developing hippocampal cells following early-life seizures
using a mouse model. The second aim will map long-lasting molecular changes to hippocampal-dependent
behavioral consequences. The central hypothesis is that early-life seizures have long-lasting cell-type-specific
effects on transcription and chromatin accessibility that may account for the long-term cognitive and behavioral
effects. The rationale for this project is that understanding these changes will ultimately present new treatment
opportunities. The research proposed in this supplement application is highly innovative because it takes a new
approach to understanding the long-term sequalae of early-life seizures by leveraging leading-edge advances
in single-cell multiomics. The research aligns with the aims of the parent project by examining molecular and
functional effects of early-life epilepsy at cellular resolution, while addressing career training goals for Ms.
Townsend and promoting diversity in scientific research.

Public health relevance
Project Narrative Children experiencing early-life seizures have increased risk of long-term cognitive and behavioral deficits. This project will elucidate the molecular effects of early-life seizures at single-cell resolution and test for behavioral correlates in a mouse model. This knowledge has potential to advance treatments for the long-term sequalae of early-life epilepsy.